Mechanisms and Models of Testis Specific Serine Kinase 6: A Novel Therapeutic Target in Colorectal Cancer

Tumors frequently re-activate genes whose expression is otherwise restricted to
gametogenic tissues including the ovary, placenta and testes. Tumorigenic expression of
these genes, known collectively as cancer-testes antigens (CTAs), has been documented
for over 25 years, however functional knowledge of the contribution of these gene
products to tumorigenesis remains scant.
In our preliminary research, we have discovered that the CTA Testis-Specific
Serine Kinase 6 (TSSK6) is expressed in more than 50% of colorectal cancer (CRC)
cases. Importantly, elevated TSSK6 expression correlates with reduced relapse-free
survival in CRC. Although TSSK6 is crucial for male fertility, knockout mice otherwise
develop normally. These findings suggest that targeting TSSK6 could offer a wide
therapeutic window if it is essential for tumorigenic behaviors. Indeed, initial studies
have revealed that suppressing TSSK6 expression inhibits anchorage-independent
growth, invasion, and in vivo growth of CRC. Conversely, introducing TSSK6 into non-
transformed colonic epithelial cells or CRC cell lines lacking TSSK6 promotes these
tumorigenic phenotypes. Notably, the oncogenic behavior of TSSK6 depends on its
kinase activity. Additionally, TSSK6-expressing cells exhibit increased resistance to a
range of therapeutics. Our initial data suggests that these phenotypes are mediated by
signaling of TSSK6 at focal adhesions that enhances adherence and survival signaling.
This proposal is centered on a a comprehensive investigation into TSSK6's
influence on focal adhesion formation and signaling (Aim 1) and its influence of tumor
metastases, viability and chemoresistance in mouse and organoid models. By achieving
these aims, we will reveal a previously unknown signaling pathway, driven by the
aberrant expression of a testes kinase, that facilitates the acquisition of invasive
phenotypes in cancer. This work is expected to provide functional biomarkers and
credible model systems essential for pursuing TSSK6 as a therapeutic target.

Public health relevance
One of the most challenging aspects of cancer treatment is the identification of therapies that kill cancer cells, but not healthy tissue. We have found that tumor cells co-opt a system that is required for sperm morphology to promote migratory and invasive behavior that leads to metastases. By studying this mechanism in detail, we will be able to identify a new therapeutic entry point for selectively inhibiting metastatic growth of cancer cells.